Measuring and Mapping Trajectories of Risk and Resilience for Suicidal Thoughts and Behaviors in Sexual and Gender Minority Preteens

PROJECT SUMMARY/ABSTRACT
Today's sexual and gender minority (SGM) youth are coming out at increasingly younger ages, with the
average age of disclosure at 13 years old and 35% coming out as preteens. SGM preteens experience up to
14 times higher risk for suicidal thoughts and behaviors (STBs) compared with their heterosexual, cisgender
peers. SGM preteens' social and developmental contexts likely contribute to significant risk and protective
factors for STBs. For example, they must simultaneously navigate preteen developmental stressors and
supports (like peer relationships and first romantic experiences) while also managing an emerging SGM
identity and associated exposure to stigma-related stress and resilience. Yet, several knowledge gaps remain.
The field of SGM preteen research is in its infancy, without consensus on best practices for sampling and
recruiting high-risk SGM preteens. The field also lacks psychometrically valid assessments for SGM preteens
as well as longitudinal studies assessing risk and resilience trajectories during this sensitive developmental
period. The overarching goal of this rigorous multi-method project is to address these gaps. Youth and parent
advisory boards will be assembled to enrich our research and ensure its cultural responsiveness, ethical
soundness, and ultimate benefit to SGM preteens and families. Our research will address three aims. First, we
will use a five-step Delphi process to develop consensus among a diverse panel of experts (including
researchers, clinicians, legal experts, parents, leaders of SGM community youth groups) on best practices for
safely, ethically, and effectively sampling, recruiting, and retaining SGM preteens at risk for suicide into
research. Second, we will create and pretest an assessment of stigma-related stress and resilience for SGM
preteens using a three-phase approach (developing an initial item pool; refining items; establishing content
validity with SGM preteens). Last, we will enroll a national cohort of 120 SGM preteens at risk for suicide with
one parent/caregiver, which we will call the SPARK (SGM Preteens Advancing ouR Knowledge) Cohort.
SPARK participants will be administered an online assessment battery of developmental stressors and
supports, stigma-related stress and resilience, and STBs every 6 months for 2 years. Analyses will use
rigorous weighted generalized estimating equations to estimate trajectories of risk and protective factors for
STBs. Subgroup analyses will further examine how trajectories of STBs and associated risk and protective
factors differ by race and ethnicity, gender identity, and other theoretically informed intersectional factors
among SGM preteens. This research is guided by an innovative conceptual model integrating advances in
developmental science with the NIMHD SGM Health Disparities Framework and involves community partners
at SGM youth organizations nationwide to enhance feasibility. Findings from this project will advance best
practices for sampling SGM preteens, measuring stigma-related stress and resilience, and mapping
trajectories of risk and protective factors for STBs, aligning with key NIMH priorities.

Public health relevance
PROJECT NARRATIVE Preteen suicide is a growing public health crisis, and the substantially greater risk for suicidal thoughts and behaviors reported among sexual and gender minority (SGM) preteens is concerning. Consistent with NIMH programmatic priorities, this project will deploy an innovative mixed-methods approach incorporating advisory board and expert feedback, measurement development, and longitudinal data collection and analysis to study risk and protective factors for suicide in SGM preteens. Given the disproportionate risk for suicide among SGM preteens and the dearth of prospective research involving this high-risk population, this project represents a novel scientific advancement to inform suicide prevention.